Administrative Supplement for COVID-19 Impact on K23 Effectiveness and Implementation of Brief Cognitive-Behavioral Therapy for Health Anxiety in Primary Care

PROJECT SUMMARY
This application for a Mentored Patient-Oriented Research Career Development Award (K23) is designed to
provide the applicant with the training needed to propel him into a productive career as an implementation
scientist focused on overcoming the barriers that limit access to effective psychosocial interventions for anxiety
and related disorders. The applicant is a clinical psychologist with existing skills in large data analyses and
experimental design, and an emerging proficiency in the identification and resolution of impediments to access
to care. The career development plan is mentored by experts in intervention development, evaluation, and
implementation, who are dedicated to ensuring that the applicant gains expertise in 1) clinical effectiveness
trials methods, 2) implementation science, and 3) team science to test optimal implementation strategies in a
psychiatrically ill population. These advanced skill domains will be critical to his success as an independent
investigator. Developing as an independent investigator with expertise in these methods will improve the
delivery of cognitive-behavioral interventions by identifying and eliminating barriers to implementation of
evidence-based practices.
Cognitive-behavioral therapy has gained an unprecedented level of empirical support over the past five
decades. Despite success in developing and testing cognitive-behavioral therapy, the dissemination of
cognitive-behavioral therapy into healthcare settings has not matched empirical support and enthusiasm from
the scientific community. The application of cognitive behavioral therapy as a technology in the treatment of
disorders of health anxiety is further complicated by features of these disorders that lead to rejection and
under-engagement with treatment. This complexity provides an opportunity to harness implementation science
to develop more effective strategies to deliver evidence-based practices to the population.
The applicant has developed a detailed research project that matches the research objectives to the career
development skill domains. The research proposal consists of a 1) hybrid effectiveness-implementation trial to
evaluate the feasibility, acceptability, and preliminary effectiveness of brief CBT for health anxiety delivered in
primary care by MAs on patient engagement and patient outcomes, 2) developmental formative evaluation to
further identify facilitators and barriers to implementation of the intervention in routine practice using qualitative
interviews with clinical practice staff, and 3) pilot of the implementation strategy in a practice setting after
modifying the intervention to address barriers and utilize facilitators. A planned follow-up trial will provide an
opportunity to demonstrate the applicant's expertise in effectiveness trial methods, implementation science,
and team science, as he builds a scientific team capable of conducting a cluster-randomized trial of the
implementation strategy piloted in this project.

Public health relevance
PROJECT NARRATIVE The proposed study aligns with the career development plan aimed at producing an expert researcher with strengths in clinical effectiveness designs, implementation science, and team science. The study will test the effectiveness of a brief cognitive-behavioral therapy provided by Medical Assistants for health anxiety in the primary care setting, identify barriers and facilitators of implementation, and pilot implementation in a practice setting. The results of this study will be used to support a cluster-randomized trial of the implementation strategy tested in this pilot project, with the aim of increasing access to effective care, decreased prevalence of excessive health anxiety, and decreased burden on the healthcare setting.